Hawaii Minority Health and Cancer Disparities SPORE

Project Summary/Abstract
At the root of health disparities is the diversity that exists in the biological, behavioral, sociocultural, and
environmental characteristics of individuals and populations. Hawai`i offers exceptional opportunities for minority
health research due to its uniquely diverse population with varying cancer burdens and its high-quality health
care and cancer registration. The University of Hawai`i Cancer Center has a successful track record of leveraging
Hawai`i's multiethnic population to study racial/ethnic differences in cancer risk and outcomes. It has built a
community-facing infrastructure to translate these findings into major biological discoveries and clinical
innovations that would help to alleviate cancer disparities in the US. We propose in this P50 (PAR-20-305) to
establish a SPORE program to conduct translational research focusing on Asians Americans, Native Hawaiians
and Pacific Islanders (AANHPI), the fastest growing US minority, to initially address three cancers of particularly
high relevance. Project 1 will address the high rates of hepatocellular carcinoma (HCC) in this population by
implementing a randomized lifestyle intervention among AANHPI patients with non-alcoholic fatty liver (NAFLD)
and by investigating mechanistic biomarkers (cell-free and leukocyte DNA methylation) that may also provide
much needed clinical management tools. We will test the efficacy of intermittent vs. continuous energy restriction
to reverse the progression of NAFLD in AANHPI, the most common etiology of chronic liver disease and liver
cancer in this population. Project 2 will address the excess lung cancer burden experienced by Native Hawaiians
by developing a risk-based and culturally-informed lung cancer screening strategy, and investigate the mutation,
methylation and transcriptomic profiles of lung squamous cell and small cell carcinomas and adenocarcinomas
that contribute to the unexplained poor survival in this vulnerable population. Project 3 will address the very high
breast cancer burden of Native Hawaiians and the rising rates in Asian Americans by testing the adequacy of
current radiomic risk prediction algorithms for predicting breast cancer in these populations and by investigating
related molecular and histopathologic features of breast tumor environment which may be related to visceral
adiposity and have prognostic significance. We will also establish: 1) an Administrative Core with strategic
planning, advisory and evaluation components; 2) an Outreach and Recruitment Core (ORC) facilitating
studies among minorities; 3) a centralized biorepository of paired fresh-frozen tumor and blood samples, as well
as archival tumor blocks (Pathology & Biospecimen Core); 4) a Biostatistics & Bioinformatics Core; 5) a
Developmental Research Program to fund innovative pilot studies and a Career Enhancement Program to
support promising investigators new to translational research; and 6) new collaborations, with other institutions
for the further translation of our findings. The successful completion of this grant will significantly advance our
ability to reduce the high burden of liver, lung and breast cancers in AANHPI and to conduct other innovative
translational minority health research that will benefit Hawai`i, the Pacific region and the rest of the US.

Public health relevance
Project Narrative We propose to establish a SPORE program leveraging Hawai`i's multiethnic population and the University of Hawaii Cancer Center's community-facing translational research infrastructure to conduct minority health research among Asian Americans, Native Hawaiians and Pacific Islanders (AANHPI). We will test innovative approaches to address ethnic/racial disparities in non-alcoholic fatty liver disease (NAFLD) (a liver condition that may lead to chronic liver disease and liver cancer), lung cancer and breast cancer, and develop additional innovative translational research that will benefit Hawai`i, the Pacific region and the rest of the US.